Policy implementation for cancer control in Nigeria

Project Summary
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
24-039. Policy is a powerful tool for achieving cancer control goals globally, however virtually no studies have
examined how policymakers in Africa, make policy decisions using research evidence. Furthermore, effective
dissemination of scientific research evidence can increase the likelihood that policymaker’s decisions are
aligned with evidence to control cancer, however a research-to-policy gap persists, with limited knowledge on
dissemination strategies that influence policymakers’ engagement with research evidence for cancer control.
This study aims to improve the use of research evidence among Nigerian policymakers and then develop data-
driven dissemination strategies that promote research on vaccine preventable cancers using audience
segmentation and designathons. Guided by the Exploration, Preparation, Implementation and Sustainment
framework, our specific aims are: 1) Use qualitative in-depth interviews and priority mapping exercises to
explore policy actor characteristics and organizational climate factors related to research evidence use and
preferences for vaccine preventable cancers (i.e. cervical and liver cancer) in Nigeria; 2) Empirically identify
and determine sub-groups of policy actors at various organizations focused on cancer control in Nigeria and
their distinct preferences and evidence use behaviors using latent class analysis; and 3) Use designathons
with sub-groups of policy actors to design and assess the acceptability, appropriateness, and feasibility of
dissemination strategies for research evidence use. Our overarching goal is not to create a monolithic “one-
size fits all” research evidence or dissemination strategies for cancer control policies in Nigeria, but to
demonstrate that our use of audience segmentation and designathons can be used to address policy and
dissemination science knowledge deficits for cancer control policies on vaccines for preventable cancers, in
Africa’s most populous country.

Public health relevance
Project Narrative The proposed project will begin to address the knowledge gap in research evidence use for vaccine preventable cancers among policymakers in Nigeria. Integrating methods from the fields of policy dissemination research and participatory methods, we will identify preferences and priorities for research evidence use and develop a data-driven dissemination strategies to increase uptake of research evidence by policymakers. Findings will address policy and dissemination science knowledge deficits for cancer control policies on vaccines for preventable cancers, in Nigeria, Africa’s most populous country.